A contraceptive decision support tool and maternal and child outcomes

Despite almost all postpartum women wanting to delay their next pregnancy by at least two years, contraceptive use remains inconsistent, particularly in Ghana, which has one of the highest levels of unmet needs for family planning in sub-Saharan Africa. Prior research has shown the quality of contraceptive care in Ghana is poor, with many women adopting methods known to cause side effects women indicated were unacceptable to them. Contraception is a preference-sensitive health service; there are often multiple medically appropriate options available to women, and so their own preferences ought to drive the decision of whether or not to use contraception, and if so, which method. Increasing client autonomy has been recognized as the next frontier in improving the quality of contraceptive care women receive. In this project, our longstanding collaborative, cross-national, interdisciplinary team will tailor an mhealth intervention to postpartum women and follow them for two years post-delivery to determine the impact of the
tablet-computer based decision-support tool on contraceptive autonomy, maternal mental and physical health, and health of the index baby. This study, conducted by a collaborative team from the University of Michigan and the Kwame Nkrumah University in Ghana, aims to improve the understanding and usage of postpartum contraceptives and the impacts of using My Family Planning-Ghana (MFPG), an adaptation of a US-based decision-support tool. To achieve this, the project focuses on three objectives.

The first aim is to adapt MFPG for postpartum women, including those undecided about contraception, using the ADAPTITT framework. By testing the tool in postnatal and child welfare clinics, our goal is to make the tool feasible, acceptable, and sensitive to the needs of postpartum women. In the second aim, we will assess the tool's impact on contraceptive behavior through a cluster-randomized controlled trial. This study will enroll pregnant women in their third trimester and follow them for twenty-four months to determine whether the tool increases contraceptive autonomy, access to preferred methods, and selection of methods that meet users’ preferences. It will also assess the tool's impact on birth spacing, pregnancy outcomes, maternal health, and contraceptive autonomy over a two-year period. The third aim will examine whether using the decision-support tool is associated with improved health outcomes and resource investment
for infants and children. The study will assess whether children of women in the intervention group have superior nutritional status, growth, health, breastfeeding duration, and healthcare usage compared to those in control group.

This project provides an opportunity to improve contraceptive autonomy in the postpartum period, a global issue of which poor quality contraceptive care is a significant part. The intervention seeks to empower women to use contraception that meets their preferences if they want to and assists in achieving their fertility goals and healthy birth spacing, and could be adapted for use in other countries, including the United States. The research team combines expertise and exceptional research infrastructure to conduct a feasible, rigorous study of a tool with potential for high impact.

Public health relevance
While nearly all postpartum women wish to delay another pregnancy by at least two years, and using contraception is one way to avoid pregnancy, postpartum contraceptive use varies widely. West Africa has the second lowest contraceptive prevalence rate and the second highest total fertility rate in the world. In Ghana, West Africa, 28% of all women of reproductive age and 27% of adolescents aged 15-19 reported using modern family planning in 2022. While the majority of postpartum women in Ghana know about family planning and want to prevent pregnancy for at least a year, 84% of women who report wanting to use contraception in the postpartum period do not do so. Birth spacing of at least two years is associated with reduced under-five mortality and improved nutritional outcomes, demonstrating links between postpartum contraceptive use and child outcomes. Quality of contraceptive care in Ghana remains poor, despite large investments in provider training and improving supply chains. An important component of contraceptive care is patient-centeredness–the extent to which patients’ services are responsive to individual needs and desires. The current patient-provider interaction lacks patient-centeredness and information is biased, inaccurate, and incomplete. Contraception is a preference-sensitive health service: with often multiple medically appropriate options available and a range of individual goals surrounding contraceptive use, the process by which a woman decides whether, and which, method to use is highly personal. A new indicator of quality and person-centeredness is contraceptive autonomy; however, no longitudinal studies have investigated the link between unbiased contraceptive education and contraceptive behavior, autonomy, and maternal health. While prior studies have identified that children of women with greater autonomy in household decision-making, care-seeking, and mobility have improved nutritional status, healthcare utilization, and lower under-five mortality, no prior studies have measured the relationship between contraceptive autonomy and child outcomes. Our longstanding collaborative team from the University of Michigan and the Kwame Nkrumah University of Science and Technology in Ghana has conducted extensive foundational work in this area. We adapted My Birth Control, an English-language interactive contraception decision-support tool that has improved the quality of contraceptive counseling and informed decision-making in the United States, for use among low-literacy women in Ghana to assist in family planning decision-making. The adaptation, called My Family Planning Ghana (MFPG), includes local-language audio and culturally relevant content, specifically for women seeking family planning and choosing between methods. In preliminary field tests, the tool was well-received and showed promise in improving knowledge and reducing misconceptions about family planning. We will further adapt the tool to focus on the unique needs of postpartum women and assess its impact in three aims: Aim 1: Use the ADAPT-ITT framework22 to adapt the My Family Planning Ghana (MFPG) decision-support tool to be used among postpartum women, including those who have not yet made the decision to use family planning, expanding the reach of such an intervention outside the family planning clinics to reach a wider population who might benefit. We will work closely with our technology partner to iteratively adapt the MFPG decision-support tool. By asking women visiting postnatal/child welfare clinics to beta-test MFPG, we will continue to adapt until it is determined to be feasible, acceptable, appropriate, and sensitive. Aim 2: Assess the impact of using an interactive, computer-based decision-support tool on contraceptive behavior. Pregnant women in their third trimester will be recruited from antenatal clinics to enroll in our cluster-randomized controlled trial, where women in the intervention facilities will have access to MFPG at all child health and immunization clinic visits (versus none). Women will be contacted approximately two weeks after their estimated delivery date to determine their contraceptive use status, then monthly for the first year postpartum and quarterly for the second year. We will determine if women interacting with the decision-support tool have higher levels of contraceptive autonomy, whether those who desire to use contraception are able to access a wanted method at a different rate than those in the control group, and if they choose methods with attributes that meet their stated preferences. We will also estimate the impact of the intervention on adolescent users (sub-aim 2.1) and birth spacing, pregnancy, maternal mental and physical health, and contraceptive autonomy in the two-year period after the index delivery (sub-aim 2.2). Aim 3: Estimate whether the intervention is associated with improved health outcomes and resource investment in children. We will test whether children born to women in the intervention arm have better nutritional status, growth, and overall health status, and whether they have longer duration of breast-feeding and greater healthcare utilization (versus the control arm). We will estimate whether contraceptive autonomy affects the same set of child outcomes and the impact of the intervention on children of adolescent mothers and conduct mediation analyses to determine pathways of impact on child outcomes. Impact: Poor-quality contraceptive care is a problem worldwide, particularly in the postpartum period, including in the United States. This U.S.-developed m-health intervention has the potential to increase the number of women who are able to use a method of contraception that meets their preferences and allows them to reach their fertility goals while achieving healthy birth spacing. We anticipate this type of intervention could be adapted to other countries, including the United States. Our application combines an excellent opportunity to feasibly and rigorously study a potential tool to improve contraceptive autonomy in the postpartum period, including among adolescents, with an exceptional team and research infrastructure.